2022 Mammary Gland Biology GRC and GRS

PROJECT SUMMARY
The Gordon Research Conference on Mammary Gland Biology (GRC MGB) and the highly successful Gordon
Research Seminar (GRS) that accompanies this meeting are unique amongst breast cancer conferences as
they bring together a very diverse mix of scientists and clinician-scientists interested in the molecular and cellular
mechanisms that govern normal mammary gland development, normal physiology, tumor initiation and
progression and metastasis. There is a strong focus on breast cancer prevention and treatment (based on
elucidating the early and later events that contribute to breast cancer onset and progression) and emerging
`cutting edge' science relevant to the field. The Mammary Gland Biology GRC/GRS is the only conference that
focuses on understanding the normal biology and development of the human breast and the mammary gland in
model systems, and their relationship to tumorigenesis to understand events that give rise to breast cancer and
has become a `must attend' event for mammary gland biologists and cancer researchers (particularly in basic
and translational research areas).
We aim to 1) uphold the MGB GRC tradition of providing a platform for established and new experts to present
new scientific findings and novel ideas; 2) stimulate discussions between established investigators with trainees
during informal sessions to train the next generation by its current leaders and promote mentorship.
To fulfil Aim 1, we have organized a program including international experts to address a wide range of
fundamental scientific issues, who will present their latest unpublished findings during the talks and during poster
sessions. The conference program will include short talks selected from abstracts, providing opportunities for
outstanding work by junior investigators and trainees. Plentiful time will be assigned for questions after each oral
presentation to further encourage discussion. Discussions after the talks, during poster sessions, and more
informally during meals and afternoons will stimulate forward thinking in both the mammary gland, breast biology,
and breast cancer fields. Presentations and discussions of these new findings and innovations will contribute to
deepen our understanding of breast cancer initiation, progression and metastasis and will provide the basis to
develop further tools to tackle this heterogenous disease in the clinic. In addition, by bringing together a diverse
collection of scientists to address emerging scientific problems bridging the breast cancer, prevention and risk
factors, lactation and mammary development areas, this meeting will generate a unique and creative atmosphere
that spurs innovative thinking and collaborations and contributes to important advances each year.
To fulfil Aim 2, opportunities to attend the “Power Hour” and informal "Lunch with the Expert" sessions and
“Under the tree discussions” where trainees and senior investigators meet to meet, discuss science, as well as
opportunities and challenges in the context of career development, will enhance the development of the next
generation of mammary gland/breast cancer biologists.

Public health relevance
NARRATIVE Despite significant progress in breast cancer research and clinical advances, breast cancer remains the most frequently diagnosed cancer worldwide. There is an unmet clinical need for better prevention strategies, early detection and more effective and specific treatments. The latest unpublished findings in a broad range of basic breast biology and breast cancer research will be presented with the goal to stimulate discussions and synergy among leaders in the field and trainees that lead to research studies that aim to improve treatment options and outcomes for breast cancer patients.